Tuning the anterior cingulate from the outside in: a new way forward for treating mental health disorders and beyond

Project Summary
This Pioneer Award application seeks to develop a suite of low intensity focused ultrasound
strategies for a wide range and severities of brain disorders with psychiatric underpinnings. The
dorsal anterior cingulate has repeatedly been implicated in such disorders ranging from
depression and obsessive-compulsive disorder to substance abuse and chronic pain. Together,
these conditions impact many tens of millions of Americans who do not respond to available
treatment. Not surprisingly, attempts to ablate and even apply deep brain stimulation to the
anterior cingulate have been attempted with some success, though adoption has been limited
due to the invasive and/or irreversible nature of these strategies. Focused ultrasound delivery at
low intensity presents an exciting non-invasive, neuromodulatory opportunity but there remains
need for high resolution methodologies to hone and optimize the approach. My lab has piloted
such methodologies recently for the proposed projects here using anterior cingulate
electrophysiology both as a biomarker to guide deep brain stimulation targeting and
parameterization and as an objective read-out of symptoms and treatment effect. Project 1
outlines the plan to leverage the same, standard intracranial recording strategies in humans to
optimize precision and delivery strategy of externally delivered low intensity focused ultrasound.
A better optimized external ultrasound strategy may provide meaningful relief to a large
subpopulation of these patients but is expected to have limited utility for more severe cases in
which dangerous breakthrough symptoms develop in between recurring treatments. These
cases will be in need of more sustainable, continuously available treatment, demanding an
implantable strategy. The implant envisioned to meet the needs of patients who have failed
conservative options (including externally delivered ultrasound) is an incisionless,
endovascularly implanted device capable of low intensity ultrasound delivery guided by anterior
cingulate electrophysiology. Project 2 will focus on testing and developing procedural feasibility
and safety of such implantation using an ovine model and will allow for developing signal
processing techniques to explore an individual's specific anterior cingulate electrophysiological
signals transvenously. Project 3 will leverage the ultrasound parameter testing from Project 1
and electrophysiological recordings from Project 2 to guide development of a fully implantable,
closed-loop system designed with the capability to deliver low intensity ultrasound to the
adjacent anterior cingulate guided by local electrophysiology detected from the central inferior
sagittal sinus.

Public health relevance
Project Narrative Dysfunction within the dorsal anterior cingulate cortex has been implicated in a large breadth of brain disorders with psychiatric underpinnings. Targeting neuromodulation using focused ultrasound in lieu of ablative strategies to this region holds promise as an important therapeutic strategy, but substantial optimization is needed to make this a viable treatment. In addition, the serendipitous adjacency of the dorsal anterior cingulate to the centrally located inferior sagittal sinus provides an incredible opportunity to leverage this anatomical relationship to develop an incisionless, intravascular ultrasound device-based strategy from bench to bedside.